Significance of Genetic Alterations in Neuroblastoma

Neuroblastoma is a common and often fatal childhood malignancy of the peripheral nervous system. There is marked heterogeneity in disease presentation; clinical course and outcome. However, the majority of patients have locally aggressive and/or metastatic disease that is often refractory to intensive multimodal therapies. Clinical variables such as age at diagnosis, disease stage and histopathologic grade are important in distinguishing between these divergent phenotypes, but biological and genetic features of the tumor provide critical additional prognostic information. Our group and others have identified nonrandom genomic alterations that occur in specific subsets of cases. Thus, we hypothesize that the pattern of somatically acquired genomic alterations present at diagnosis in primary neuroblastomas can independently predict clinical course and disease outcome. We will test this hypothesis through a prospective and systematic analysis of genomic-based candidate prognostic markers in all neuroblastoma patients enrolled on Children's Oncology Group (COG) clinical trials. In addition, we plan to identify new genetic alterations critical to the development of the highly malignant subset of neuroblastomas. First, we will determine the independent prognostic significance of allelic alterations at chromosome bands 1p36, 11q23, 14q32 and 17q23-25 when these variables are entered into a multivariate analysis, individually and in combinations, with all current prognostic variables. Second, we will develop a microarray-based molecular diagnostic approach for neuroblastoma by using a customized cDNA-based neuroblastoma-specific "chip". This array should provide a standardized approach to sensitive, specific and reproducible detection of clinically relevant tumor-specific alterations. Third, we will identify novel prognostic markers critical to the development of high-risk disease. We will perform clinical correlative studies in a prospectively identified group of 150 representative cases to determine the clinical significance of recently described genomic alterations. Promising candidate markers would then by analyzed in the full patient cohort. In addition, we will perform genome-wide expression profiling designed to identify the unique patterns of gene expression present in strictly defined clinicobiological subsets. The successful completion of the proposed research will allow us to unequivocally define the genetic alterations present in human neuroblastoma and to use these data to predict clinical phenotype and response to treatment. These studies will therefore provide the infrastructure necessary to apply tumor- specific data to treatment planning algorithms for future patients with neuroblastoma, and thus this project may contribute to improved survival probabilities. It is also expected that these studies will identify novel genes and/or pathways that are unique to the high-risk subset of tumors. It is expected that these will be of prognostic importance and serve as specific targets for developmental therapeutics.